Developing Protein-based MRI Biomarkers for Alzheimer's Disease

Alzheimer's disease (AD),
ABSTRACT
the leading cause of dementia in the elderly, is a devastating neurodegenerative
disease. The hallmarks of this devastating disease are the accumulation of amyloid plaques and neurofibrillary
tangles, as revealed by standard histopathologic examination at postmortem. A large number of strides have
been made in past years to identify and validate biomarkers for AD. Based on PET and CSF measures of the
plaques and tangles of AD, we are now able to measure AD pathology in vivo at all stages: AD dementia, mild
cognitive impairment (MCI), and preclinical AD. Notably, the recent NIA/AA AT(N) research framework focused
on the diagnosis of AD with biomarkers in living individuals and encouraged the continued development of new,
unrecognized AD biomarkers. Amide proton transfer (APT) imaging is a relatively new protein-based MRI
technique that can generate contrast based on endogenous mobile proteins and peptides in tissue. Numerous
previous studies have demonstrated that APT-weighted (APTw) imaging can detect malignant brain tumors
based on increased cell density and acute cerebral ischemia due to tissue acidosis or decreased pH. Our effort
has successfully developed this important MRI technology into an FDA-approved sequence on Philips 3T MRI
systems for clinical use with brain cancer. Further translating this innovative protein-based technology to AD and
non-AD proteinopathies, such as dementia with Lewy bodies (DLB), is encouraging. It is known that both
extracellular amyloid and intracellular tau first exist as soluble monomers (APT-detectable). Our preliminary
studies have clearly demonstrated that the abnormal accumulation of these proteins in MCI resulted in an
increased APT effect and AD dementia had APTw-MRI signal characteristics distinct from DLB. The overall
goals of this application are to refine quantitative whole-brain APT-MRI methodologies on 3T clinical MRI
scanners and to demonstrate the feasibility and potential of protein-based APT-MRI as a surrogate biomarker for
the characterization and diagnosis of AD and other forms of dementia, such as DLB. We have formulated three
specific aims that we plan to address in the coming five years: (i) develop a time-efficient APT-MRI protocol for
an imaging study of AD; (2) quantify the accuracy of APT-MRI in characterizing and diagnosing MCI; and (3)
quantify the accuracy of APT-MRI in distinguishing between AD dementia and DLB. This proof-of-concept study
will lay the foundation for a full validation study that will assess the impact of APT imaging on clinical
decision-making in patients with AD and related dementias.

Public health relevance
APT imaging is capable of detecting abnormal protein accumulation associated with AD, including amyloid beta and tau protein, which will enable the early detection of AD pathology. If our aims are achieved, this project will provide the critical sensitivity and specificity data for APT-MRI to identify MCI and distinguish AD dementia and dementia with Lewy bodies. We expect to ultimately provide several entirely new, endogenous protein-based MRI biomarkers, with which to visualize AD non-invasively with routine clinical MRI scanners.